Neurohumoral Interactions Coordinating Mammalian Cardiomyocyte Size and Proliferation

Project Summary
Heart failure after ischemic injury remains a leading cause of death in the United States due to the inability of
adult humans to replace lost cardiac muscle after heart attack. In contrast, newborn mammals possess a
transient but robust capacity for complete functional heart regeneration. Cardiac regeneration in neonatal
rodents relies on the proliferation of pre-existing cardiomyocytes (CM), highlighting the importance of
understanding CM cell cycle regulation. This regenerative capacity is lost shortly after birth when the majority of
CMs undergo cell cycle arrest, polyploidization, and hypertrophic growth. The long-term goal of my proposed
research is to define the physiological triggers that mediate the postnatal loss of mammalian heart regenerative
potential. In this proposal, we build upon our recent discovery demonstrating that combined inhibition of thyroid
hormone (TH) and adrenergic receptor (AR) signaling during postnatal development increases CM proliferation,
delays polyploidization, and promotes heart functional regeneration in older juvenile mice. Despite the
significance of these findings, the cellular and molecular mechanisms downstream of these pathways impacting
CM cell division remain unclear. While TH and AR signaling are known to promote CM hypertrophic growth, the
interrelationship between CM size and cell cycle control is not well understood. Our central hypothesis is that
TH and AR signaling interactions after birth drive CM hypertrophic growth and limits proliferative
potential. We are pioneering the application of digital holographic microscopy to visualize three-dimensional
changes in CM volume in response to hormonal stimulation in real-time with single cell resolution. We are using
this technology to resolve if CM hypertrophic growth inhibits cell cycle progression and division. We will test our
hypothesis in the following specific aims: Aim 1: Determine how TH and AR signaling interactions promote CM
hypertrophy. Aim 2: Define how TH and AR signaling interactions inhibit CM proliferation. Aim 3: Identify the
molecular targets downstream of TH and AR signaling regulating CM hypertrophy and proliferation. The results of
these studies are expected to reveal new insights into the cellular and molecular mechanisms facilitating the
loss of heart regenerative capacity in mammals, which may help inform novel treatment strategies to improve
heart regenerative capacity in adult humans. This SuRE-First award will fund the research of approximately 40
undergraduates and 8 M.S students over the course of four years, including many minority trainees at San Jose
State University, a primarily undergraduate and Master’s-level institution committed to training
under-represented minority students. Undergraduates will perform the majority of the proposed work, with
training and mentorship from senior graduate students and the PI. This funding would allow the PI to continue to
develop a strong track record in research, give meaningful scientific experiences to undergraduate students,
and strengthen the research environment at San Jose State University.

Public health relevance
Project Narrative Newborn rodents possess a temporary but robust capacity for heart regeneration that is lost during the transition to adulthood. The proposed research is relevant to public health because it addresses the cellular and molecular mechanisms by which mammals lose the ability to regenerate their hearts after birth, and therefore will bear on the fields of heart development, tissue regeneration, and regenerative medicine. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to fostering fundamental creative discoveries that ultimately protect and improve human health.